Pneumonia-induced microglial activation causes blood-brain barrier breakdown, astrocyte activation, and tau pathology

PROJECT SUMMARY / ABSTRACT
Many survivors of respiratory infections (i.e., pneumonia, and SARS-CoV-2) have subsequent incident dementia
causing decreased quality of life and are at a higher risk of developing Alzheimer’s disease and related
dementias. The cause of this association between pneumonia and dementia is unknown. It is also unknown how
bacterial pneumonia causes neurovascular unit dysfunction. Pseudomonas aeruginosa is a pathogen capable
of causing bacterial pneumonia and can elicit cytotoxic tau from the mouse lung and induce neuronal tau seeding,
reduce dendritic spine density, and impair synaptic plasticity and cognition in mice. Additionally, I have shown
that P. aeruginosa causes microglia and astrocyte activation, blood-brain barrier breakdown, and tau pathology
in wild-type mice 24 hours post-infection. At lower doses of P. aeruginosa, I have seen microglia activation but
no blood-brain barrier dysfunction. Microglia can influence blood-brain barrier breakdown and tau pathology as
well as regulate neuroimmune pathways. Taken together, this has led to the hypothesis that pneumonia first
causes microglia activation, leading to blood-brain barrier breakdown, and tau phosphorylation in the brain. Using
a quadruple labeled mouse model (PrismPlus), I will image longitudinally from just 3 hours post-infection to
elucidate the temporal resolution and mechanisms of neurovascular unit dysfunction in the brain. I will also
assess neurovascular unit dysfunction in matched pneumonia vs. non-pneumonia post-mortem brain and lung
tissue. This project will be the first step towards developing novel and effective therapies to protect neurovascular
function in patients with severe lung infections, while allowing me to master the amazing technique of multiphoton
imaging of mouse brain through a cranial window. Migraine disorders have a global prevalence of approximately
15% and are the third highest cause of disability-adjusted life years. However, much is still unknown about the
pathology of migraines, particularly at the capillary level, and more effective treatments are needed. For the K00
phase, I will utilize my mastery of intravital imaging of the neurovascular unit at the capillary level, to investigate
neurovascular and neuroimmune mechanisms in migraine mouse models.

Public health relevance
PROJECT NARRATIVE Neurovascular unit dysfunction is seen in many neurological disorders, including post-pneumonia delirium and migraine. In this project, I will determine how bacterial pneumonia infection, specifically, if pneumonia-induced microglia activation first causes neurovascular unit dysfunction in vivo in experimental models, and differences in neurovascular unit state in pneumonia vs. non-pneumonia post-mortem human brain. For my postdoctoral project, I will utilize the methods I master during my PhD training to investigate the mechanisms of neurovascular dysfunction at the capillary level in migraine mouse models.